Endothelial progenitor cells and neurovascular injury in the aging brain

Project Summary
The proposed study will investigate the role of endothelial progenitor cells in neurovascular dysfunction and
cognitive decline among older adults with low levels of traditional vascular risk and normal baseline cognitive
function. Specifically, we will study whether changes in endothelial progenitor cell proliferation and senescence
are predictive of cognitive decline, vascular brain lesions and structural and functional brain connectivity. We will
also study secretory factors from endothelial progenitor cell cultures to better understand how progenitor cell
function relates to neurovascular dysfunction, brain injury and cognitive decline.

Public health relevance
Project Narrative The current proposal investigates markers of endothelial progenitor cell reserve and senescence in relation to cognitive decline, neurovascular injury and brain dysfunction in older adults. Findings will have direct relevance for our understanding of early systemic risk factors and protective factors that may indicate risk for dementia due to Alzheimer's disease and vascular disease.